Stress effects on virus protein induced inflammation and sickness behavior

Project Summary/Abstract
Myalgic Encephalomyelitis/Chronic Fatigue Syndrome (ME/CFS) is a complex disorder characterized by
profound fatigue, as well as immune and neurocognitive dysfunction. The etiologies and the drivers of ME/CFS
remain unknown and there are no useful biomarkers for distinguishing the various subgroups. Our innovative
studies over the ten previous years of this award have demonstrated that the deoxyuridine triphosphate
nucleotidohydrolases (dUTPase) encoded by the Epstein-Barr virus (EBV) and more recently by the human
herpesvirus 6 (HHV-6) have novel immunoregulatory and neuroregulatory functions that contribute to the
pathophysiology observed in a subgroup of patients with ME/CFS. In this renewal application, we will continue
our mechanistic studies to define the role that the EBV and HHV-6 dUTPases have in ME/CFS. Our overall
hypothesis is that the increased abortive replication of EBV in plasmablasts/plasma cells in a subgroup of
patients genetically susceptible to developing ME/CFS induces the increased synthesis and release of EBV
dUTPase in exosomes. Ligation of EBV dUTPase-containing exosomes with TLR2 present on antigen-
presenting cells (APCs) in the local microenvironment triggers the production of pro-inflammatory TH1
cytokines as well as activin A, which in turn stimulates the differentiation and proliferation of follicular helper T
(TFH) cells, resulting in IL-21 production, which contributes to the immune dysfunction observed in these
patients. Activin A is also a negative regulator of muscle growth and we are proposing that it alters the function
of key enzymes in skeletal muscle leading to oxidative stress and low energy levels thus, contributing to the
post-exertional fatigue characteristic of patients with ME/CFS. Trafficking of EBV dUTPase containing
exosomes to the brain and TLR2 ligation on target cells results in microglia activation, disruption of the BBB,
neuroinflammation and altered synaptic plasticity ultimately leading to cognitive impairment in these patients.
Finally, these physiological effects of the EBV dUTPase are enhanced by chronic stress. The results of this
study, will demonstrate that the EBV/HHV-6 dUTPases may act as drivers of the immune activation that occurs
in ME/CFS. It may also identify EBV/HHV-6 dUTPase proteins as diagnostic biomarkers for identifying a
subset of patients with ME/CFS. Finally, these studies will demonstrate that engagement of EBV/HHV-6
dUTPase proteins with TLR2 is essential for inducing neuroimmune dysfunction and thus, this interaction can
be used as a novel target for the development of alternative therapeutic approaches.

Public health relevance
Narrative Myalgic Encephalomyelitis/Chronic Fatigue Syndrome (ME/CFS) is a complex disorder of unknown etiology and there are currently no biomarkers available to identify individuals with ME/CFS or to distinguish various subgroups of patients with ME/CFS. Our studies have demonstrated in a subgroup of patients with ME/CFS that the deoxyuridine triphosphate nucleotidohydrolase (dUTPase) proteins encoded by the human herpesviruses (Epstein-Barr virus & human herpesvirus-6) exert their novel biological effects by acting as a pathogen associated molecular pattern (PAMP) triggering the activation of TLR2 or TLR2/1, which are expressed on numerous cell types, inducing signaling cascades that result in the modulation of pathways involved in immunity, energy production and neuronal function. This multidisciplinary research grant will provide new information on the mechanisms by which the herpesviruses -dUTPases may induce immune dysregulation, post-exertional fatigue and cognitive dysfunction as it relates to ME/CFS, provide potential biomarkers and identify targets that may be used for the development of dUTPase-specific therapeutic agents for a subgroup of patients with ME/CFS.